Cellular Interactions in Vascular Calcification of Chronic Kidney Disease

ABSTRACT
Patients with chronic kidney disease (CKD) have high cardiovascular mortality, and this could be partly due to
the development of vascular calcification, which is characterized by a pathological deposition of calcium and
phosphate in the arterial walls. Vascular calcification is common in patients with CKD due to the accumulation
of uremic toxins and metabolic disturbances such as hyperphosphatemia. Unfortunately, there is no effective
treatment to prevent or slow the progression of vascular calcification. Our overarching aim is to identify new
therapeutic targets to treat vascular calcification by studying the interaction between two major vascular cell
types—endothelial cells (ECs) and vascular smooth muscle cells (VSMCs). In the pathogenesis of vascular
calcification, while osteogenic differentiation of VSMCs is the key process, EC-VSMC interaction also appears
to be important, yet EC-VSMC interaction is not well-studied. To address this knowledge gap, we have
assembled a multidisciplinary team of experts and established an insert co-culture system of primary human
aortic ECs and human aortic VSMCs. Compared to mono-culture, this co-culture system allows us to model
distinct aspects of the multi-cellular environment in vivo. We will test the central hypothesis that uremic serum
from patients with severe CKD alters EC secretome, which in turn induces osteogenic differentiation of VSMCs
and calcification. Studying uremic serum takes into account the complex metabolic alteration in CKD and has
great translational potential. Our two aims are (1) to define the paracrine effects of ECs on phosphate induced
calcification of VSMC culture; (2) to determine the effects of uremic serum via EC-VSMC signaling on
osteogenic differentiation of VSMCs and calcification. In Aim 1, using medium containing high phosphate,
VSMCs will be cultured with or without ECs, or with ECs transfected with small interfering RNA targeting
phosphate transporters to block the intracellular uptake of phosphate. Then, we will elucidate the role of the
nitric oxide pathway in EC-VSMC paracrine signaling and identify novel signaling pathways by examining
cellular secretome using an unbiased approach of SILAC (stable isotope labeling of amino acids in cell
culture)-based quantitative proteomics. In Aim 2, VSMCs will be cultured with or without ECs, and in the
presence of uremic or normal serum. Uremic serum will be obtained from patients with end stage kidney
disease receiving hemodialysis and compared to normal serum from age- and sex-matched healthy
volunteers. Then, we will quantify cellular secretome using SILAC-based proteomics to identify specific
paracrine factors, and fractionate serum using chromatography to isolate the components of uremic serum that
promote calcification. Studying EC-VSMC signaling will help identify new therapies that can attenuate vascular
calcification, making this proposal significant. With the use of human uremic serum, primary human cells in an
insert co-culture system, and SILAC-based proteomics, this project is highly innovative and has great
translational potential.

Public health relevance
PROJECT NARRATIVE Vascular calcification is prevalent and contributes to high cardiovascular mortality in patients with chronic kidney disease. This research proposal will provide new insights into the pathophysiology of vascular calcification and has the potential to guide new treatment strategies to reduce mortality in patients with chronic kidney disease.